CORE A-ADMINISTRATION

The Administrative Core (Core A) is led by Dr. Michela Gallagher, who serves as the P.I. of this
Program Project grant. The Administrative Core plays an integral role in the research program by coordinating
activities and interactions between the Cores and individual projects. The roles of the Administrative Core
include 1) animal/tissue assignment to the Projects from Core B, 2) transfer of Core B data for routine analysis
and archiving by Core C, and 3) oversight of data transfer from the Projects to Core C, achieving an
organizational structure whereby all records of planned research, active experiments, and completed research,
including publications, are coordinated and maintained with a central point of contact.
The Administrative Core provides leadership for the organization of program events and meetings,
including meetings with our external scientific advisory board. The participation of a scientific advisory group in
our planning/review process provides valuable oversight and consultation. In addition to such meetings, all
investigators, including Core and Project Leaders are updated on the work in the research program through
regular group meetings and Core A’s internal data sharing function. Together, these activities are integral to
guiding the research program through each annual cycle of planning, discovery, and evaluation of research
findings. In these functions, the Administrative Core contributes significantly to the integration of work in the
research program across Projects with transparency and building consensus on decisions.
The Administrative Core has well-established procedures for all of its functions. With respect to the
assignment of resources for experiments (animals and tissue), under our long-established system, unique
identifiers for each subject/sample ensure that studies in the Projects are conducted blind with respect to
cognitive status. Data transfer through the Administrative Core to Data Management (Core C) provides a clear
point of contact to ensure complete archiving (data obtained/transferred for all assigned animal resources) and
for tracking progress on research in the Projects. The meetings of the entire program project, along with
updates managed by the Administrative Core, are integral to the review of our progress, plans for the future,
and integration of the program. The Administrative Core also provides routine support for the overall Program
Project (oversight of finances, compliance with all NIH guidelines, progress reports and continuation
applications). Finally, in addition to its functions in resource sharing (animals/tissue, data) within the research
program, the Administrative Core also oversees, manages, and coordinates targeted resource sharing with
outside investigators.